Administrative Core

The Administrative Core is designed to encourage scientific interchange, provide scientific oversight and coordinate the day-to-day administrative, financial and secretarial operations of the program. Its goals are: AIM #1: To coordinate and foster scientific exchange amongst projects and investigators and between investigators and other interested parties in the University of Pittsburgh research community. A1M#2: To provide scientific oversight to the Program grant AIM#3: To provide administrative, financial and secretarial support to the Program grant.